Mentoring of Early Career Researchers from Diverse Backgrounds

PROJECT SUMMARY
There is a critical need to train the next generation of scientists and promote diversity in this workforce to improve
care for children with kidney disease. Effective mentoring at early career stages is fundamental to successful
career advancement in biomedical research. The candidate for this NIDDK Investigator Award to Support
Mentoring of Early Career Researchers from Diverse Backgrounds is Michelle Denburg, MD, MSCE. Dr.
Denburg is an Associate Professor of Pediatrics and Epidemiology at the University of Pennsylvania Perelman
School of Medicine (PSOM) and is a practicing pediatric nephrologist at the Children's Hospital of Philadelphia
(CHOP). PSOM and CHOP offer an ideal setting for collaboration, mentorship, didactic training, and
opportunities in patient-oriented research, and Dr. Denburg’s leadership roles and responsibilities are highly
synergistic with the goals of this award. Dr. Denburg’s multidisciplinary research program is focused on
managing complications of and improving health outcomes in childhood kidney diseases, including chronic
kidney disease (CKD), glomerular disease, and kidney stone disease, with a particular interest in bone health
and altered mineral and vitamin D metabolism. Her research includes analyses of large electronic health record
databases, ancillary studies to existing NIDDK-funded prospective cohort studies, and observational,
translational, and interventional patient-oriented studies. Dr. Denburg has a long-standing and demonstrated
commitment to research and career mentoring. Over the past 12 years, Dr. Denburg has mentored over 35
individuals from diverse backgrounds across multiple disciplines, institutions, and career stages. The majority of
these individuals have continued their careers in academic medicine and remain engaged in research. With this
award, Dr. Denburg aims to continue to provide effective mentoring in the conduct of rigorous patient-oriented
pediatric research to early career researchers from diverse backgrounds, with a focus on recruiting and
mentoring individuals from populations that have been underrepresented in science and medicine. Dr. Denburg
will pursue additional evidence-based training programs designed to reinforce and enhance skills in culturally
aware mentoring of early career researchers from diverse backgrounds. She will develop sustainable mentoring
approaches that contribute to the wider mentoring environment and expand training infrastructure and resources
to promote research in kidney disease at CHOP and Penn. Dr. Denburg’s long-term career goals are to conduct
interdisciplinary clinical and translational research that improves the health and well-being of children and young
adults with kidney disease and to catalyze the careers of trainees from diverse backgrounds to become
independent investigators in kidney disease research. Support from the K26 award will help sustain her active
mentoring program and expand her mentoring capacity to enable her to take on 1-2 new postdoctoral mentees
and at least one predoctoral summer student each year of the proposed award, with a focus on mentoring of
individuals underrepresented in medicine.

Public health relevance
PROJECT NARRATIVE Michelle Denburg, MD, MSCE is an Associate Professor of Pediatrics and Epidemiology at the University of Pennsylvania Perelman School of Medicine (PSOM) and is a practicing pediatric nephrologist at the Children's Hospital of Philadelphia (CHOP). Dr. Denburg is committed to and has a long-standing track record of research and career mentoring across the early career spectrum, from students to junior faculty. Support from the K26 award will help sustain her active mentoring program and expand her mentoring capacity, with a focus on mentoring of individuals underrepresented in medicine.